Training in Biomolecular Pharmacology

PLEASE SEE RESEARCH TRAINING PROGRAM PLAN

Public health relevance
Awarded Narrative The Program in Biomolecular Pharmacology at Boston University is designed to train predoctoral students in pharmacological research and discovery, combining the fundamental principles of pharmacology with novel approaches drawn from bioinformatics, biophysics, biochemistry, biomedical engineering, chemistry, genetics, molecular medicine and neuroscience. Trainees undertake an integrated curriculum that emphasizes translation of rigorous basic science research and acquisition of scientific skills for careers in academia, government or the private sector.